Addressing Shortcomings of AAV GeneTherapies for the Muscular Dystrophies

Abstract
This Wellstone Muscular Dystrophy Specialized Research Center is focused on optimizing AAV-mediated
gene therapies for Duchenne and Limb Girdle Muscular Dystrophy. We are developing novel approaches to
address deficiencies we have identified in the existing human AAV-gene therapies for the muscular dystrophies.
Our first goal (Project 1) is to design and optimize miniaturized utrophin-dystrophin chimeric transgenes that can
be delivered using a single AAV vector to the skeletal muscles and hearts of animal models of DMD, the human
iPSC-derived engineered heart tissues of Project 2, and eventually to humans. Secondly, we will work to design
and test improved AAV capsids and transgenes in collaboration with Project 2 with the goal to reduce
immunostimulatory activity. Project 2 will design and test AAV gene therapy for sarcoglycan deficiency. These
include the design and optimization of AAV-gene therapy vectors for SGCG-LGMD with enhanced transgene
expression and stability, and reduced immunostimulatory activity. Project 2 will evaluate the optimized AAV-
SGCG vectors in vivo and demonstrate functional restoration in heart and muscle. Lastly, Project 2 will test AAV-
transgenes from Projects 1 and 2 in a humanized mouse model of anti-AAV immunity for chemokine stimulation,
liver toxicity, and T cell mediated capsid responses. Project 3 entails a clinical study that will follow the skeletal
and cardiac muscle progression of micro-dystrophin treated boys and sarcoglycan-deficient individuals using
non-invasive biomarkers and functional outcomes. These projects will work together for the common goal of
improving the safety and efficacy of gene therapies for muscular dystrophies, directly comparing data across
Projects to ascertain transgene-specific and platform-related results. Project 3 will collaborate with Project 1 to
perform tissue validation of T1/T2 measures with tissue histology in the dystrophic rat (MDR). Project 3 will also
work with Project 1 to characterize the MR response to AAV therapy and assess blood flow in muscles pre- and
post-AAV treatment. Project 3 will collaborate with Project 2 to provide blood samples that correlate with imaging
data. The Center will continue to make important contributions to sharing resources, maintaining our Shared
Resource Core for all muscular dystrophy researchers. We will also expand our successful training efforts,
continue to cultivate our collaborations with patient advocacy groups and industry, and maintain our outreach
efforts for the muscular dystrophy community.

Public health relevance
Narrative: This Wellstone Center will design and test improved AAV-mediated gene therapies for Duchenne and Limb Girdle Muscular Dystrophy. The Center will also follow and evaluate muscular dystrophy patients who have received an AAV gene therapy as well as patients prior to AAV treatment.